Development of a Biochemical Diagnosis for Creutzfeldt-Jakob disease

DESCRIPTION (provided by applicant): Human prion diseases are infectious and invariably fatal forms of neurodegenerative diseases, including sporadic Creutzfeldt-Jakob disease (sCJD), the most common form, and variant CJD (vCJD) which is associated to consumption of cattle meat infected by bovine spongiform encephalopathy. Currently there is not sensitive, objective and non-invasive biochemical diagnosis for these diseases, and even less a procedure to detect people incubating the disease in the pre-symptomatic period. This is a major problem for public health, because prion diseases are known to transmit iatrogenically between human-to-human and because due to the long pre-symptomatic stage of the disease-which may span five decades-the asymptomatic carriers far outnumber the clinically affected individuals. To make the situation even more complicated, the infectious agent responsible for these diseases, termed prion, is composed exclusively of a conformationally altered form of a naturally occurring protein, named PrPSc, which has the unique ability to infect individuals and propagate in the body without the need for genetic material. PrPSc is not only the infectious agent and the likely culprit of neurodegeneration, but also the best surrogate marker for the disease. The challenge is that its quantity is high only in the brain at late stages of the disease However, compelling evidences indicate that PrPSc is present in minute amounts in various peripheral tissues and biological fluids. The main goal of this proposal is to develop a blood- and cerebrospinal fluid (CSF)-based detection assay for PrPSc associated with sCJD and vCJD. Our strategy utilizes two pioneering proprietary technologies developed in our lab: First the protein misfolding cyclic amplification (PMCA) technique which enables to amplify the amount of PrPSc present in the sample to detect as little as a single molecule of PrPSc. PMCA, has a similar power of amplification as PCR and allowed us to detect, for the first time, prions in blood and urine, even at the pre-symptomatic stages of the disease. Second, PrPSc-specific monoclonal antibodies (called PrioC) raised against prion-infected brain homogenates in PrP knock out mice. In this project we will optimize a technology combining PMCA amplification of PrPSc with detection by sandwich ELISA using the PrioC conformational antibodies. The assay will be optimized using animal and human samples for high throughput detection of prions in biological fluids, and will be validated for sensitivity and specificity according to the requiremets of the regulatory authorities with the aim to obtain approval for commercialization. The results generated in this project may lead to the first biochemical test validated for the diagnosis of CJD. With this validated technology, Amprion will establish an International Reference Laboratory for the Detection and Eradication of human prion diseases. PUBLIC HEALTH RELEVANCE: Development of a biochemical assay for the sensitive, early and non-invasive detection of prions in biological fluids of patients affected by human prion diseases is a top medical priority to decrease further spreading of these infectious diseases and to help efficient treatment. This project combines two pioneer technologies to produce an assay that has the unique possibility to detect prions in blood and cerebrospinal fluid of patients and even in asymptomatic carriers of infectious prions. In this project we have put together the relevant technical and business expertise, secured the availability to key samples and already began working with regulatory authorities to get the successful validation and approval of the test.

Public health relevance
Development of a biochemical assay for the sensitive, early and non-invasive detection of prions in biological fluids of patients affected by human prion diseases is a top medical priority to decrease further spreading of these infectious diseases and to help efficient treatment. This project combines two pioneer technologies to produce an assay that has the unique possibility to detect prions in blood and cerebrospinal fluid of patients and even in asymptomatic carriers of infectious prions. In this project we have put together the relevant technical and business expertise, secured the availability to key samples and already began working with regulatory authorities to get the successful validation and approval of the test.